Georgia CaRes

Abstract:
Augusta University has been home to Georgia’s NCI Community Oncology Research Program since 2014. In partnership with University Blood and Cancer Center in Athens, Phoebe Putney Medical Hospital in Albany, Augusta Oncology Associates in Augusta, and Dwight D. Eisenhower Army Medical Center in Augusta, the Georgia CaRes NCORP has over 1550 enrollments in NCI clinical trials (including cancer control, treatment, biospecimens, and special entries). The main goals of this application are to sustain and grow our NCORP Community Site, focusing on improving patient outcomes in cancer care throughout the State of Georgia and beyond. Our original program was aptly named Georgia CaRes (Georgia Cancer Research) and represents our shared commitment to cancer research including studies in cancer control, cancer prevention, and cancer care delivery, as well as clinical trials from NCI’s National Clinical Trials Network (NCTN). The renewal of Georgia CaRes will allow us to continue to serve large portions of the state with high concentrations of rural populations. We will accomplish this through the following Specific Aims: 1) Georgia CaRes will facilitate participation and enrollment of patients and healthcare providers into cancer control, prevention, and cancer cared delivery research (CCDR) studies developed by NCI’s Research Bases and in human research trials of the National Clinical Trials Network (NCTN); 2) Georgia CaRes will support and strengthen NCORP goals by improving the scope of our activities as an NCORP Community Site; 3) Georgia CaRes will increase collaboration across our NCORP Community network and with the Research Bases. Renewal of Georgia CaRes will have a significant and far-reaching impact on the health of cancer patients within the State of Georgia and beyond.

Public health relevance
Narrative: A large portion of Georgia consists of rural communities that do not have adequate cancer prevention and treatment care options. The Georgia CaRes NCI Community Oncology Research Program (NCORP) aims to provide cancer prevention and control trials, cancer care delivery research (CCDR) trials, and cancer treatment trials to Georgia’s rural communities. Georgia CaRes can continue to significantly and positively impact the public health, especially with respect to cancer in rural communities in Georgia and beyond.